Characterization of native AMPA receptor structure and function in glioblastoma

PROJECT SUMMARY
Mixed lineage leukemia is an aggressive subset of acute leukemias with poor clinical outcome and a severe
need for improved treatment options. A genetic hallmark of mixed lineage leukemia is chromosomal translocation
of the MLL gene, resulting in the formation of MLL-fusion proteins that drive leukemogenesis by mislocalizing
essential cellular epigenetic machinery. Many MLL-fusion partner proteins interact with the histone
methyltransferase Dot1L, mistargeting its activating methylation mark to developmental regulatory genes that
are native targets of MLL during development. Dot1L catalytic activity is essential for both leukemogenic
transformation and maintenance, making Dot1L inhibition one of the major strategies underlying current
therapeutic development. Defining the molecular basis of Dot1L activity is an essential step towards rational
development of Dot1L-targeted therapeutics, but our understanding of the structural and mechanistic basis for
Dot1L activity on its native nucleosome substrate is still incomplete.
Dot1L methylation of its target histone H3 lysine 79 residue is dependent on prior ubiquitylation of its nucleosome
substrate on histone H2B at lysine 120. However, the structural basis for this trans-histone crosstalk has not
been established. To elucidate the mechanistic basis for Dot1L activity on its nucleosome substrate and identify
novel strategies for Dot1L inhibition, we solved a 3.9Å cryo-EM structure of Dot1L bound to a site-specifically
ubiquitylated nucleosome, providing the first high-resolution insight into how Dot1L engages with its nucleosome
substrate and is regulated by ubiquitin. Guided by this structure, we identified residues in Dot1L essential for
both its nucleosome-specific activity and upregulation by ubiquitin. In Aim 1, we will mutate these Dot1L residues
to observe their effect on leukemia cell viability and Dot1L activity at known oncogenes. This work will define the
nucleosome-specific and ubiquitin-dependent activities of Dot1L in leukemogenesis and probe the potential of
the Dot1L-nucleosome and Dot1L-ubiquitin interfaces as therapeutic targets.
Many MLL-fusion partner proteins are also components of the super elongation complex (SEC), a large
transcriptional regulatory protein complex that promotes the elongation phase of transcription by releasing RNA
polymerase II from promoter-proximal pausing. The SEC is also essential for leukemogenic transformation in
mixed lineage leukemia, further promoting misregulation of gene expression at MLL-fusion target genes through
overactivation of transcriptional elongation. Still, the structural organization of the SEC and the influence of MLL-
fusions on SEC structure and function has not been explored. In Aim 2, I propose a complete structural and
functional characterization of the SEC to determine the mechanistic basis for SEC-driven leukemogenic
progression in the context of MLL-fusion proteins.
Together, these aims will identify novel targets along the molecular pathways driving leukemogenesis to form
the pre-clinical foundation for rational therapeutic development.

Public health relevance
PROJECT NARRATIVE The enzyme Dot1L drives overexpression of oncogenes that are essential for the initiation and progression of mixed lineage leukemia, an aggressive subset of acute leukemias with no known cure and limited effective clinical treatments. Here we illustrate the molecular basis for Dot1L activity by identifying the interfaces between Dot1L and its nucleosome substrate that are essential for oncogene activation by Dot1L. By establishing the disease-relevance of these Dot1L-nucleosome interaction interfaces in mixed lineage leukemia, this work will inform the development of novel targeted therapeutics to combat this deadly disease.